Systems-based approaches for investigating tissue communication during exercise

ABSTRACT
Daily physical activity is a known intervention to prevent or ameliorate complications associated with
metabolic-related diseases. However, the mechanisms underlying metabolic adaptations to chronic exercise
training remain inadequately understood. Moreover, human studies show a broad range of exercise
adaptation with some individuals refractory to specific metabolic improvements associated with training.
Since conventional animal studies have focused primarily on few rodent strains, in the current application
we will interrogate exercise training adaptations in ~100 diverse male and female strains of inbred mice
known as the UCLA Hybrid Mouse Diversity Panel (HMDP), and integrate these data with existing MoTrPAC
data repositories at the Bioinformatics Center (BIC), Stanford University. In Aim 1 we will determine the
regulatory loci controlling exercise metabolism and integrate several “omics” platforms (transcriptomics,
proteomics, metabolomics) using Bayesian analyses and Mergeomics to identify regulatory networks and
key driver nodes underlying exercise training in mice and validate these findings with publicly available data
from the MoTrPAC consortium studies of exercise training in rats and humans. In Aim 2 we will use
Quantitative Endocrine Network Interaction Estimation (QENIE) to functionally annotate novel inter-tissue
communication circuits (between cardiac and skeletal muscle, and liver, and fat) that are critical for
endurance exercise adaptation. Our findings provided herein show remarkable, sex-specific tissue crosstalk
that occurs to maintain metabolic homeostasis and in response to exercise. We will construct
communication networks between the four tissues in mouse and validate these against the plasma
proteome of human and rat (provided by the MoTrPAC consortium BIC) similar to multi-species validation
studies published previously by our group (PMCID6399495, 5935137). Moreover, we will also perform
molecular validation studies confirming exercise-stimulated changes in novel circulating factors, and
determine functionality of these communication networks using conventional loss and gain of expression
approaches. Our findings will be of strong scientific impact as we will identify novel exercise-induced
regulatory nodes and key driver pathways underlying improvements in metabolism, determine novel
exercise driven endocrine interactions, and generate a mouse sample biobank and data repository that will
be integrated into the MoTrPAC data hub for novel hypothesis generation by the entire research community.

Public health relevance
PROJECT NARRATIVE Metabolic dysfunction and insulin resistance are underlying features of many chronic diseases, and daily physical activity is one of the only interventions known to reverse complications associated with metabolic-related disease. In this proposal we will use novel informatics approaches on multi-omics analyses of tissues and complex traits described during/following acute/chronic exercise for humans, rats, and a large panel of inbred and recombinant inbred mice, to determine the molecular driver nodes responsible for adaptations to metabolic health that occur as a consequence of physical activity. Additionally, the proposed studies will generate a large tissue and data resource to be integrated into the existing MoTrPAC tissue and data repositories, and our publications from this work will provide a template of informatics platforms and scientific approaches that collectively can be leveraged by the research community to advance novel therapeutic target discovery.